BLR&D Research Career Scientist Application

Neurodegenerative disorders [e.g. Alzheimer's disease (AD) and Parkinson's disease (PD)] are a group of
devastating conditions that are caused by progressive death of neurons in different regions of the brain. On
the other hand, multiple sclerosis (MS) is the most common autoimmune disease of the central nervous
system, resulting in oligodendrocytes death and demyelination. Our lab primarily focuses on central nervous
system (CNS) cell signaling that leads to neuronal death in Parkinson's disease (PD) and Alzheimer's
disease (AD) and demyelination in multiple sclerosis (MS). All these disorders are characterized by
activation of CNS glial cells (astroglia and microglia), excessive production of different proinflammatory
molecules within the CNS, and death of either oligodendroglia (MS) or neurons (AD and PD). From several
angles, we have been investigating mechanisms by which glial cells are activated to release different
proinflammatory molecules and neurotoxins for inducing apoptosis and cell death in neurons and
oligodendroglia. We are also involved in identifying signaling pathways by which glial cells may be
redirected to produce neuroprotective molecules and neural stem cells could be driven towards neurons and
myelin-producing cells (oligodendrocytes) within the neurodegenerative CNS. Finally, we are trying to
suppress neurotoxic signaling pathways and/or boost neuroprotective signaling pathways in different animal
models of neurodegenerative diseases by nontoxic drugs in order to achieve neuroprotection. Since many
veterans are suffering from dementia, AD, PD, and MS, results from these studies will directly help veterans.
1

Public health relevance
Our lab primarily focuses on central nervous system (CNS) cell signaling that leads to neuronal death in Parkinson's disease (PD) and Alzheimer's disease (AD) and demyelination in multiple sclerosis (MS). We will try to suppress neurotoxic signaling pathways and/or boost neuroprotective signaling pathways in different animal models of neurodegenerative diseases by nontoxic drugs in order to achieve neuroprotection and functional recovery. 1